Inspiratory muscle strength training for lowering blood pressure and improving endothelial function in postmenopausal women: comparison with "standard of care" aerobic exercise

PROJECT SUMMARY
This application is in response to NOT-AG-21-018, Alzheimer’s-focused administrative supplements for NIH
grants that are not focused on Alzheimer’s disease. Aging is the primary risk factor for mild cognitive
impairment and Alzheimer’s disease. Women make up two thirds of all Alzheimer’s disease diagnoses.
Specifically, postmenopausal (PM) women with above-normal systolic blood pressure (SBP ≥120 mmHg),
i.e., >75% of PM women in the U.S., are at the highest risk for mild cognitive impairment and dementias. A
primary mechanism linking above-normal SBP to cognitive decline is cerebrovascular dysfunction, i.e.,
impaired cerebral blood flow regulation, which is mediated by excessive reactive oxygen species (ROS)-
induced oxidative stress and reductions in nitric oxide (NO) bioavailability within the cerebrovasculature.
Aerobic exercise (AE) is a first-line intervention for lowering SBP that can reduce the risk of mild cognitive
impairment and Alzheimer’s disease. However, in PM women with above-normal SBP, AE only decreases
casual (resting) SBP by ~3 mmHg and is ineffective at improving cerebrovascular function. In addition, only 25-
30% of PM women meet guidelines for 150 min/week of moderate-intensity AE, often due to a lack of time.
High-resistance inspiratory muscle strength training (IMST) is a novel, time-efficient lifestyle intervention
that involves 30 inhalations/session against a resistive load using a portable hand-held device – a program that
requires only ~5 min/day. Results from the PM women in our NIA R21-funded pilot trial show that 6 weeks of
IMST (6 days/week) promoted adherence (94% of sessions completed), lowered SBP (-7 mmHg) and
improved episodic memory (domain of cognition closely linked to mild cognitive impairment/Alzheimer’s
disease) and cerebrovascular function vs. sham (low-resistance inhalation) training. IMST also changed
systemic circulating factors that reduced oxidative stress and increased NO bioavailability in endothelial cells.
Our parent award is a randomized clinical trial assessing 3 months of high-resistance IMST vs. moderate-
intensity AE for lowering SBP in PM women with above-normal SBP. We propose to extend our parent trial to
assess IMST for improving episodic memory and other cognitive domains closely linked to mild cognitive
impairment and dementia, and for improving cerebrovascular function by decreasing oxidative stress and
increasing NO bioavailability. This research is highly relevant to Alzheimer’s disease and related dementias
as it will evaluate a novel time-efficient lifestyle intervention for improving cognitive function and established
mild cognitive impairment/Alzheimer’s disease risk factors in asymptomatic at-risk PM women with above-
normal SBP, a group disproportionately burdened by Alzheimer’s disease. Leveraging our ongoing clinical
trial will stimulate research regarding Alzheimer’s disease and related dementias by providing initial evidence
for the efficacy of IMST for decreasing dementia risk and promoting translation of this time-efficient, adherable
intervention to other at-risk populations or groups with established mild cognitive impairment or dementia.

Public health relevance
PROJECT NARRATIVE Postmenopausal (PM) women with above-normal systolic blood pressure (SBP) are at a disproportionate risk for mild cognitive impairment, Alzheimer’s disease and related dementias. Aerobic exercise, a lifestyle intervention for decreasing dementia risk, has modest effects on SBP and does not improve cerebrovascular function in PM women, and is associated with poor adherence. This administrative supplement seeks to establish the efficacy of high-resistance inspiratory muscle strength training, a time- and effort-efficient lifestyle intervention, for improving cognitive and cerebrovascular function when compared to aerobic exercise training in asymptomatic, at-risk PM women with above-normal initial SBP.